A RANDOMIZED CLINICAL TRIAL OF UMBILICAL ARTERY CATHETER PLACEMENT

This project was formulated to determine if very low birth weight infants who receive umbilical artery catheters that are placed high in the thoracic aorta (T6-T8) are at higher risk of intraventricular hemorrhage than are infants that receive an umbilical artery catheter placed low in the abdominal aorta (L4- L5). We propose to randomize infants to receive either a high or low catheter and then to review the incidence of intraventricular hemorrhage. The project will enroll a total of 650 infants in several neonatal intensive care units beginning in 1989.